A Path Towards Leveraging AI to Enable Point-of-Care MR Devices for Disease Detection

Project Summary
Prostate Cancer (PCA) is the second most prevalent malignancy and a leading cause of mortality among men
in the United States. The urgency for early identiﬁcation of Clinically Signiﬁcant Prostate Cancer (CSPCA) within
the at-risk population cannot be overstated, as it holds the key to signiﬁcantly enhancing clinical outcomes. Yet,
the current standard-of-care for CSPCA surveillance, the Prostate Speciﬁc Antigen (PSA) test, is plagued by low
speciﬁcity, resulting in a cascade of unnecessary advanced diagnostic imaging and invasive biopsy procedures,
inﬂicting a substantial wasteful cost burden on the health system and subjecting patients to avoidable trauma.
Despite the established efﬁcacy of Magnetic Resonance Imaging (MRI) in diagnosing CSPCA, it is not used as a
ﬁrst-in-line tool to identify patients with CSPCA at the population level. The reluctance to embrace MRI is rooted in
the requirement to generate high-ﬁdelity images, imposing inherent challenges – the need for expensive scanners
installed in specialized imaging centers, executing complex and slow protocols tailored to acquire copious high-
quality k-space data, and the dependence on sub-specialized radiologists for image interpretation.
Driven by our mission to democratize MR diagnostics for widespread surveillance of critical illnesses like
CSPCA on a population scale, we challenge the conventional wisdom that high-ﬁdelity images are necessary
for accurate disease inference. Instead, we advocate for inferring disease presence directly from a meticulously
curated subset of degraded k-space data. We hypothesize that modern Machine Learning (ML) models can
accurately infer the presence of the disease (a binary decision - which is all that may be required for disease
surveillance) using only a minimal amount of carefully selected degraded k-space data. This carefully chosen
degraded data, that would otherwise be insufﬁcient to generate a diagnostic-quality image, can be swiftly acquired
using inexpensive and accessible scanning devices, thereby paving the way for making MR technology accessible
for disease identiﬁcation at the Point-of-Care (POC). In this proposal we will ﬁrst establish the feasibility of ML
models to accurately detect CSPCA directly from a ﬁxed under-sampled k-space data, without images (Aim 1).
Subsequently, we will determine the minimum quantity of k-space data required for accurate disease detection,
irrespective of image quality, by proposing an innovative end-to-end ML methodology that identiﬁes a diminutive
subset of k-space containing ample information for precise CSPCA inference and uses it to draw conclusions
about CSPCA presence (Aim 2). Finally, we will aim to show that CSPCA can be accurately inferred from the
degraded k-space data acquired using low-ﬁeld scanners, without images (Aim 3). Findings of this project will
establish the groundwork for affordable and accessible MR devices that maintain accuracy in detecting CSPCA.
These devices, capable of operating closer to the POC for disease surveillance, will promote equitable access to
MR diagnostics beyond specialized environments, revolutionizing disease surveillance on a broader scale.

Public health relevance
Project Narrative The current standard-of-care, the PSA blood test, falls short in effectively surveilling Clinically Signiﬁcant Prostate Cancer (CSPCA) at the population level due to its low speciﬁcity, leading to an abundance of unnecessary and costly follow-up imaging and invasive biopsy procedures, placing unwarranted burden on the health system and causing avoidable patient trauma. While Magnetic Resonance Imaging (MRI) has proven its value in diagnostic imaging, it is not employed as a ﬁrst-in-line tool for this task, because of its poor accessibility and high-friction usage, stemming from the extensive collection of high-quality frequency space measurements necessary for re- constructing high-ﬁdelity images. With an overarching goal of democratizing MR-based diagnostics and bringing its beneﬁts closer to point-of-care, this proposal sets forth the essential parameters for machine learning-enabled MR systems by establishing the bounds on data requirements for such systems that can accurately detect CSPCA without reconstructing images.